Heme utilization and homeostasis in Pseudomonas aeruginosa

DESCRIPTION (provided by applicant): Pathogenic bacteria require iron for their survival and ability to cause infection. Many bacterial pathogens have evolved sophisticated systems to utilize heme as a primary source of iron. The opportunistic pathogen P. aeruginosa is an increasingly common cause of nosocomial infections with high morbidity associated with such infections. In addition to their natural resistance to many antibiotics the alarming increase in such infections highlights the need for alternate antimicrobial strategies. In previous biochemical and biophysical studies we have characterized the intracellular heme trafficking protein PhuS and the iron-regulated heme oxygenase HemO and have further shown they are critical for heme utilization and virulence. The specific aims of the proposal are to further elucidate the mechanism of extracellular heme utilization and regulation as it relates to virulence. This will be achieved through; i) Elucidating the intracellular heme trafficking pathway and defining the role of biliverdin IX-delta and -beta isomers in the extra-cellular feedback regulation of heme uptake through genetic, biochemical, and metabolomics approaches. ii) Defining the mechanism of heme transfer from PhuS to HemO through a combination of site-directed mutagenesis, biochemical and biophysical studies and iii) Determining the role of the regulatory small RNA PrrH in heme uptake and utilization. These studies will provide new insights into heme and iron homeostasis in bacterial pathogens. We will through this proposal identify new heme metabolic and regulatory pathways as novel antimicrobial targets and advance the current understanding of heme transfer mechanisms.

Public health relevance
PUBLIC HEALTH RELEVANCE: The rapid rise in antibiotic resistance in the past two decades increases the need for alternative therapeutic strategies. A current approach to developing new antibiotics is to target non-essential functions that reduce virulence but decrease the selective pressure on the organism to undergo mutation. Heme utilization provides such a target and elucidation of the molecular mechanisms of heme trafficking and utilization will aid in identifying novel therapeutic targets.